Biophysical mechanisms underlying Drosophila renal tubule morphogenesis

PROJECT SUMMARY/ABSTRACT
Organs have specific three-dimensional (3D) architectures that are essential for their physiological functions. By
integrating chemical and physical inputs, cells build and sculpt complex 3D tissue shapes. Understanding the
molecular and physical architectural rules governing the formation of our organs could offer insights into how
deviations from these rules contribute to human diseases. Despite the prevalence of looped epithelial tubular
structures throughout our organs we lack fundamental knowledge of the strategies cells use to build these
complex tissue structures. The goal of my research program is to understand the emergent properties cells use
to sculpt organ shapes. To achieve this goal, we use the developing Drosophila renal system which involves the
generation and extension of epithelial tubes that bend and loop in 3D in a stereotypic manner. This experimentally
tractable system is ideal to identify the parameters that generate complex tissue forms while keeping the cells in
an in vivo context. Here we will couple our ability to both visualize and perturb key drivers of tissue
morphogenesis to determine how these drivers influence cell shape, collective cell behavior, and ultimately organ
form. In this project, we will focus on the following questions: (1) How is contractile machinery in cells organized
to coordinate tissue-scale behavior? and (2) How do cells coordinate to dynamically pack (and repack) in a tissue
that is changing shape? To address these questions, we are developing techniques to visualize, track, and
quantify both the 3D cell behaviors and machineries that drive these tissue movements in vivo. We will build on
work by myself and others to understand the molecular and physical principles cells use to bend and extend
epithelial sheets to reveal how cells drive the formation of looped epithelial tubes. Identifying these general
principles of tissue morphogenesis will provide insight into how dysregulation of these rules leads to human
disease and provide opportunities to develop novel therapeutic strategies to treat them.

Public health relevance
PROJECT NARRATIVE During embryonic development collective movements of cells generate tissues that bend, fold, and loop in three- dimensions (3D) to build our organs. Using the developing Drosophila renal system, we will define the molecular and physical processes that cells use to sculpt complex 3D tissue forms. The molecular players involved in these processes are conserved from flies to humans, thus we can leverage this knowledge to inhibit their dysregulation to treat or even prevent congenital organ defects.